An Integrated Biomedical Dataset Discovery System for Immunological Research Databases

The The Contractor will develop a prototype of an integrated biomedical dataset discovery system for Immunological Research Databases (BIRD) to facilitate integrated search for data/knowledge/tools of interest from DAIT bioinformatics resources.